Elucidating novel epigenetic modifications implicated in multiple myeloma risk disparities

PROJECT SUMMARY
Multiple myeloma (MM), the second most common hematologic malignancy in the United States, is an
incurable plasma cell malignancy with standardized incidence rates that are typically 2- to 3-times higher
among African Americans (AA) compared to European Americans (EA). Reasons for this apparent racial/ethnic
disparity remain largely unclear. Genetic susceptibility, socioeconomic factors, and obesity are important risk
factors for MM, but they do not fully explain the excess risk of MM in AA. Epigenetic modifications, particularly
cytosine modifications, play a critical role in the development and progression of MM. However, unlike solid
tumors (e.g., breast, prostate, colon, etc.) where distinct epigenetic changes in racial/ethnic groups have been
shown to account for the differences in tumor initiation, progression, and aggressiveness, the epigenetic
contributions to the excess risk of MM in AA are not well characterized. Differences in epigenetic modifications
are an intrinsic feature between human populations and associated with complex traits and diseases. The
majority of previous epigenetic studies have used technologies that cannot distinguish 5-
hydroxymethylcytosines (5hmC), a biochemically stable epigenetic mark showed distinct genome-wide
distributions and regulatory roles from the well-studied modified cytosines, 5-methylcytosines (5mC). In
addition, epigenetic epidemiology studies have predominantly used DNA from peripheral blood lymphocytes as
surrogate specimens because obtaining CD138+ tumor cells from the bone marrow aspirates in healthy
individuals is not feasible. Therefore, we propose to elucidate the influence of novel DNA modifications,
specifically the 5hmC in circulating cell-free DNA (cfDNA) on racial/ethnic disparities in MM. Circulating cfDNA
fragments are released into the bloodstream by circulating dead or proliferating cancerous cells. Thus, cfDNA
produced by tumor cells hiding in the bone marrow, bone marrow microenvironment, or extramedullary disease
can be detected in plasma. We have demonstrated the relevance of cfDNA-derived 5hmC in MM and other
hematological malignancies, including that specific 5hmC modifications in cfDNA were associated with overall
survival of MM; distinct 5hmC signatures reflected molecular differences between subtypes of lymphoma; and
population-specific pathways involving 5hmC were identified between MM and its precursors. Our central
hypotheses are that specific 5hmC signatures associated with MM in cfDNA reflect primary tumor cells, and
specific 5hmC modifications contribute to the excess risk in AA. We will identify genome-wide 5hmC signatures
for MM in cfDNA (Aim 1) and investigate MM-associated 5hmC in cfDNA-paired bone marrow tumor cells and
microenvironment (Aim 2). We will elucidate population-specific 5hmC signatures and pathways between EA
and AA patients with MM (Aim 3). This project is significant because it offers a timely and comprehensive
strategy to identify novel epigenetic contributors to MM and its disparities that will provide new targets for
individualized preventive interventions in high-risk populations for this incurable disease.

Public health relevance
PROJECT NARRATIVE Compared with European Americans (EA), African Americans (AA) have two-to-three times higher risk of developing multiple myeloma (MM) for reasons that remain unclear. This work seeks to elucidate the influence of novel epigenetic modifications (i.e., 5-hydroxymethylation) in circulating cell-free DNA (cfDNA) as well as tumor cells and cells from bone marrow microenvironment on the excess risk of MM in AA compared to EA. Successful completion of this study will not only significantly enhance our understanding of epigenetic mechanisms that underlie the racial/ethnic differences in MM risk but also provide novel approaches for individualized prevention of this incurable disease.